Integrated software platform to enhance school mental health assessment and data-driven student services

Abstract
Mental health (MH) screening is critical to ensure early identification of youth MH needs. Schools are the most
common setting for MH service delivery to children and adolescents, therefore, improving the capacity of school-
based MH providers to easily access and use validated, high quality MH screening and assessment instruments
to identify students in need of services is a significant public health need. Unfortunately, school health and MH
professionals face several barriers to using validated MH screening tools, including lack of familiarity with and
access to established measures, scoring and interpretation challenges, and limited time and resources to set up
and administer MH assessment. Significant public health impact would be realized by investing resources in
evidence-based screening and assessment technology products that are feasible, affordable, and usable for
schools. The goal of this Direct to Phase II SBIR is to increase access to and use of established high quality MH
and MH-related assessment measures in schools. We will develop the SHARE (Student Health Assessment,
Response, and Evaluation) software system through iterative, user-centered testing. SHARE will be designed to
overcome logistical (e.g., cost, time) and implementation (e.g., administration, scoring) barriers that limit use of
available measures, so schools can feasibly implement MH screening and assessment on a routine basis and,
ultimately, narrow the gap in access to MH care for youth. This SBIR will further the successful collaboration of
3C Institute and the National Center for School Mental Health (NCSMH). 3C brings essential skills in how to build
easy-to-use, feasible technology products for schools, including research-driven platforms for online data
collection with youth, meaningful data displays, and integrated decision aids, along with an established
technology infrastructure to ensure secure data collection, transfer, and storage. NCSMH brings a nationwide
network of thousands of SMH administrators and providers through its School Health Assessment and
Performance Evaluation System (SHAPE) along with essential research and clinical expertise in SMH
assessment and services, including developing data-driven decision supports to improve SMH services. This
foundational work and collaboration provide an unparalleled opportunity to successfully move the proposed
SHARE product to market and in so doing, quickly provide schools with an effective means to assess their
students’ MH needs and elevate the quality of SMH services. Our Direct to Phase II project will accomplish three
specific aims: (1) create the fully functional SHARE software system through iterative user-centered tests, (2)
conduct a field test with SMH providers and youth, and (3) conduct a pilot test of the full SHARE system with
SMH providers, school-level administrators, and district-level administrators. This administrative supplement
will enable us to include a suite of online Professional Development modules regarding (a) cultural
competencies and (b) increasing access to treatment after assessment, thus further strengthening our
ability to meet our end goal to elevate the quality of SMH services which, in turn, has the potential for
broad-reaching public health impact for youth and families.

Public health relevance
Project Narrative Schools are the most common setting for mental health (MH) service delivery to children and adolescents; unfortunately, school health and MH professionals face a number of barriers to using validated MH screening tools, including lack of familiarity with and access to established measures, scoring and interpretation challenges, and limited time and resources to set up and administer MH assessment. These impediments contribute to the disturbing fact that two out of three youth with a diagnosable MH problem in the U.S. do not get the help they need, leading to heightened risk for chronic MH problems as well as school failure, family problems, and risky behaviors (e.g., substance use). The goal of this administrative supplement is to create online professional development (PD) training modules for the consideration of cultural diversity and for understanding the path from assessment to treatment, which will strengthen the overall goal of the parent project to increase access to and use of established high quality MH and MH-related assessment measures in schools which, in turn, has the potential for broad-reaching public health impact for youth and families.